Determining Bone Loss and Bone Mineral Density Recovery Following Repeat Pregnancy/Lactation Among HIV Women on ART

PROJECT SUMMARY / ABSTRACT
Among HIV-infected women, the longer-term impact that lifetime antiretroviral therapy (ART) with
repeat pregnancy followed by breastfeeding has on maternal health outcomes including bone mineral
density (BMD), in particular, remains unknown. Findings from the PROMISE 1077BF trial indicated that
BMD significantly decreased among asymptomatic HIV-infected mothers randomized to receive ART
during extended breastfeeding compared to mothers whose infants were randomized to receive
nevirapine prophylaxis during breastfeeding. Breastfeeding was also associated with transient decreases
in BMD but was usually followed by BMD recovery. Lactating women with HIV taking tenofovir-based
ART had altered milk mineral composition (i.e. calcium) when compared to women without HIV.
These initial results from the PROMISE trial reporting BMD decreases with ART during breastfeeding and
metabolic differences for lactating mothers on ART from the Gumba study raise concerns about
potentially increased risk of early osteopenia or osteoporosis compared to mothers are not HIV-infected
and not exposed to lifetime ART. To better understand this relationship, the Maternal Bone Health
Study (MBHS) is a prospective longitudinal follow up study being conducted to assess BMD changes with
repeat pregnancy and extended breastfeeding among HIV-infected mothers from the PROMISE trial who
are now enrolled as participants in the PROMOTE cohort. This observational MBHS is being conducted at
clinical research sites in Blantyre, Malawi and Kampala, Uganda to explore factors which may affect
bone health and both loss and recovery patterns of BMD for HIV-infected women on lifetime ART.
The Specific Aims of the MBHS are: (1) to gather baseline BMD data at entry into PROMOTE and to
compare to prior bone density scans, DXA measures, from PROMISE in order to assess changes clinical
risk factors for low BMD in HIV-infected women and (2) to determine BMD loss and recovery patterns in
from bone biomarker changes during a 36-month post-delivery period among HIV-infected women who
have a repeat pregnancy during PROMOTE follow up with results being compared to age group- and
parity-matched HIV-negative pregnant women at each site. Lastly, the MBHS will aim (3) to compare
BMD and bone biomarker findings with PROMOTE mothers matched for age group and parity by site
who do not conceive during 36 months of follow-up. These comparisons will elucidate whether
decreases in BMD among HIV-infected mothers on lifetime ART are exacerbated with repeat
pregnancy/breastfeeding and if BMD recovery after breastfeeding is further decreased when compared
to HIV-negative women at the end of breastfeeding. The long-term goal of this cohort study is to better
support the bone health of breastfeeding women living with HIV who are on lifetime ART. The
requested administrative supplement will allow completion of the crucial 36 month outcomes.

Public health relevance
PROJECT NARRATIVE The Maternal Bone Health Study (MBHS) is studying changes in bone mineral density (BMD) and bone biomarkers among mothers living with HIV on life time ART who recently delivered when compared to HIV negative mothers and mothers living with HIV who have not had a recent birth among women participants in Blantyre Malawi and Kampala Uganda. Better understanding of bone health changes and BMD loss during/recovery after cessation of breastfeeding will be important to assess later risk of adverse outcomes such as osteoporosis among women on lifetime ART. This administrative supplement if granted will allow completion of the study aims for the 36 month outcomes on changes in bone mineral density and bone biomarkers for approximately one third of study participants which were unavoidably delayed due to the COVID 19 pandemic.